Core C: External Network Core

CORE C: EXTERNAL NETWORK
Research on the social, economic, and biodemographic dimensions of aging depends on
successful interinstitutional exchange and interdisciplinary collaboration. To foster these
relationships, Duke’s Center for Population Health and Aging (CPHA) includes an External
Network Core (ENC) that connects faculty, staff, and trainees at Duke with the national and
international aging research community. The ENC will take advantage of the strengths of
biosocial research on aging in the local North Carolina Research Triangle to support
collaborative pilot proposals and an interinstitutional working group on the Social and Biological
Determinants of Health, which features a unique, cross-disciplinary focus on integrating
research in human populations and animal models. Through these activities, as well as support
for conference travel and short-term collaborative visits, the ENC will identify promising faculty
and trainees with an interest in aging research and provide crucial early stage support to grow
the aging research community. Additionally, to showcase cutting-edge, emerging work in
behavioral and social research on aging, the ENC will support themed workshops and symposia
on topics of interest to the CPHA community. These events, in combination with the established,
CPHA-supported annual meeting, “Demography Daze,” will feature important research
advances, catalyze new opportunities for collaboration, and motivate new research directions
within and outside Duke. The ENC thus takes advantage of the exceptional community of
biosocial researchers at Duke, while simultaneously building connections with faculty and
trainees on a regional, national, and global scale. It therefore advances the overarching aims of
the P30 proposal as a whole, with particular relevance to integrating social science and life
science approaches to understand aging across the life course.